Resolution of inflammation in chemical-induced cancer

PROJECT SUMMARY
While exposure to toxic environmental chemicals can mutate DNA, causing cancer, the underlying non-
genotoxic mechanisms that support malignant transformation remain largely uncharacterized. Transformed
cells require growth factors to support and stimulate them in carcinogenesis, resulting in hyperinflammation
and a cytokine storm. A paradigm shift is emerging in understanding the resolution of acute inflammation as an
active biochemical process with our discovery of novel specialized pro-resolving mediators (SPMs), such as
resolvins, and endogenous resolution programs. At nanogram doses, SPMs stimulate macrophage-mediated
clearance of debris and counter-regulate pro-inflammatory cytokine (e.g., TNFα) production without immune
suppression. Despite approaches to block systemic inflammation, there are no “pro-resolving” therapies for
cancer treatment. Furthermore, the impact of carcinogens on eicosanoids and pro-resolving lipid media-
tors, both critical regulators of the initiation and resolution of inflammation, is completely unknown. In response
to NOSI-20-018 “Promoting Fundamental Research in Inflammation Resolution,” this proposal focuses on ad-
vancing our recent results indicating that stimulating the resolution of inflammation prevents carcingogen-
induced tumor growth by counter-regulating cytokine storms. Therefore, the overarching theme of this pro-
posal is to elucidate the underlying processes of failed resolution of inflammation initiated by environmental
chemicals. We will rely on a set of established experimental systems, including genetic and pharmacological
manipulation of SPMs and their receptors in animal models and macrophage studies. In Specific Aim 1, we
will profile lipid autacoid mediators, including eicosanoids (PGs, LTs) and SPMs, as well as cytokines to test
our innovative hypothesis that environmental chemicals trigger dysregulation of SPMs that leads to an uncon-
trolled cytokine & eicosanoid storm. We will evaluate pro-resolving lipid mediators as interventional targets
in chemical-induced cancer. We will elucidate cellular, intracellular, and receptor-mediated pro-resolving and
anti-tumor mechanisms of resolvins. In Specific Aim 2, the mechanisms that mediate failed resolution of in-
flammation in chemical-induced cancer will be investigated. These studies will complement Specific Aim 3 in
a multi-pronged approach that will evaluate SPM analog mimetics and humanized nano-pro-resolving medi-
cines (NPRMs) carrying SPM cargo as novel targeted treatment approaches to prevent chemical-induced can-
cer. These studies will offer new animal models to evaluate toxic chemicals and novel therapies to counter
cancer. We will then connect our preclinical findings to clinical disease phenotypes using a new computational
framework to understand failed resolution of inflammation in chemical-induced cancers. As SPMs are safe
and effective in inflammatory disorders, the proposed studies shall provide the basis for rapid translation of
resolution-directed treatments in humans as a new direction to prevent and/or reduce cancers that arise
from environmental carcinogens.

Public health relevance
Project Narrative We recently discovered that toxic environmental and occupational chemicals stimulate cancer by disrupting the natural resolution of inflammation mechanisms that terminal and control inflammation via a cytokine storm caused by cellular debris. To stimulate the natural debris-clearing process (pro-resolution), we utilized re- solvins, small non-toxic lipid molecules produced by the human body providing an entirely new approach to combat chemical-induced cancer. We’ve assembled a team of world-class investigators to study underlying mechanisms of resolution of inflammation as an entirely novel, paradigm-shifting approach to control the cyto- kine storm and hyperinflammation caused by environmental and occupational toxins.